A Team Science Approach to the Co Development of Oral Mucosa for Therapeutic Purposes

PROJECT SUMMARY
The oral cavity soft tissues protect against pathogens, toxins, and trauma. Over 100,000 soft tissue grafts are
performed annually in the U.S. after trauma or biopsy. Current approaches, including autologous grafts,
allografts, and xenografts, have significant limitations. Autologous mucosal equivalents derived from induced
pluripotent stem cells (iPSCs) could overcome these obstacles. In this application, we propose to bioengineer
vascularized, functional grafts that can be tailored to diverse clinical needs. We have assembled a team whose
members have defined the fundamental principles of renewal in the oral mucosa, identified key progenitor
populations in both mouse and human, and established pioneering advances in bioengineering to enable
translation to patients. We propose a guided approach that integrates single cell/spatial multiomics,
developmental biology, stem cell biology, and bioengineering to address three specific aims. First, we will build
on our molecular atlas of oral tissues to identify additional pathways that regulate oral epithelial lineage decisions
through interaction with peri-epithelial fibroblasts. Second, we will develop and optimize protocols to produce
iPSC-derived oral epithelial and mesenchymal populations for tissue engineering. Third, we will engineer
vascularized, autologous oral tissue rudiments ready for soft tissue grafting. At the end of the project, we will
have generated scalable, vascularized, autologous grafts that mimic keratinized and non-keratinized mucosa
that we expect to reduce rejection and improve outcomes, positioning us to move towards applications in the
clinic.

Public health relevance
PROJECT NARRATIVE Tens of thousands of oral soft tissue grafts are performed annually in the U.S. after trauma or biopsy in the mouth, but current approaches have significant limitations. In this application, our team – consisting of experts in stem cell biology, regenerative medicine, clinical dentistry, bioengineering, and materials science – proposes to make grafts from a patient’s own stem cells that can be tailored to diverse clinical needs. At the end of the project, we will have generated grafts that mimic the normal tissues in the mouth, which will reduce rejection and improve outcomes for patients.